Implementation strategies for supporting maternal and perinatal death surveillance and response (MPDSR)

PROJECT SUMMARY/ ABSTRACT
The AMANI (Accelerating Maternal And Newborn survIval) study aims to address persistently high rates of
maternal and neonatal mortality in Kenya by improving maternal and infant death auditing and response.
Maternal and Perinatal Death Surveillance and Response (MPDSR) is a structured quality improvement (QI)
process for health workers to identify, report, review, and respond to maternal and/or perinatal deaths at a facility
level. The WHO developed MPDSR global technical guidelines and they were adopted by the Kenyan
government as national policy nearly a decade ago. However, MPDSR is rarely conducted with fidelity, in part
due to lack of health worker clarity about MPDSR steps, lack of familiarity with QI including how to identify
concrete response actions, and cultures of blame surrounding maternal or perinatal deaths. The AMANI study
builds on our team’s prior research identifying critical issues contributing to neonatal deaths during facility
delivery and identifying factors influencing guideline adherence. Through structured interrogation of these
findings with Kenyan policy makers and health workers, we co-developed a multi-component practice facilitation
package that includes audit and feedback (AF) and enhanced mentorship (EM). We will conduct a cluster
randomized trial across 20 health facilities to test the practice facilitation package using the RE-AIM
framework. In Aim 1, we assess participation in practice facilitation components in intervention facilities (Reach)
and evaluate the effectiveness of the AMANI intervention on maternal and perinatal mortality, adoption of
MPDSR following a maternal or perinatal death, and implementation of MPDSR with partial or full fidelity (primary
outcome). We will also identify determinants of implementation fidelity and track adaptations to MPDSR
implementation. A 24-month implementation phase will be followed by a 12-month maintenance phase, during
which no external practice facilitation will take place. We will evaluate if the strategy has an enduring impact on
fidelity during the maintenance phase. We will also track if AF and EM activities continue to be implemented in
intervention facilities. In Aim 2 we will investigate the primary mechanisms through which the practice facilitation
package influences MPDSR implementation fidelity. Leveraging the Information-Motivation-Behavioral skills
(IMB) model, the study team will conduct mediation analyses to determine if the strategy activates hypothesized
mechanisms of provider knowledge, social support, attitudes, and self-efficacy. Other mechanisms investigated
include psychological safety and provider burnout. By leveraging routine data sources and political support, this
study has the potential to dramatically influence progress towards achieving Sustainable Development Goals
3.1 and 3.2 by improving the implementation of the WHO-endorsed MPDSR tool. Moreover, it contributes to the
collaborative testing of a pragmatic strategy to enhance the adoption, integration, and sustainability of an
evidence-based intervention, potentially reducing preventable deaths in high mortality settings.

Public health relevance
PROJECT NARRATIVE Maternal and perinatal death audit and response are evidence-based practices which result in meaningful reductions in maternal and newborn deaths through health system changes and improved quality of care. We propose a cluster randomized trial, called AMANI (Accelerating Maternal And Newborn survIval), to determine if a practice facilitation implementation strategy package, including enhanced mentorship and audit and feedback components, can improve implementation of the World Health Organization’s Maternal and Perinatal Death Surveillance and Response (MPDSR) technical guidelines. We aim to evaluate if the AMANI strategy package improves both implementation outcomes and patient-level mortality outcomes, the stability of these changes over time after practice facilitation ends, and potential mechanisms through which AMANI affects change, which can inform pragmatic delivery of the AMANI package by governments in the future.